2024 Food Allergy Gordon Research Conference & Gordon Research Seminar

Project Summary
Food allergy affects up to 8% of the US population, but research in food allergy has lagged behind that of other
atopic diseases. There has been a marked uptick in research in food allergy in the past 10 years, contributing to
FDA approval of the first therapy for peanut allergy in 2020. There is more interest in food allergy from a variety
of disciplines, and there is a need to capitalize on this increased interest to accelerate growth in the field. We
(the Chairs of these events) are proposing the 2024 Gordon Research Conference & Seminar in Food Allergy
as a means to increase the breadth, diversity, and inclusion of our food allergy research community by bringing
together the global community of basic science and clinical investigators, invested organizations, and
stakeholders to discuss recent advances in our understanding of immune mechanisms involved in the induction
of tolerance versus allergic responses to food and the application of these principles to emerging treatment
approaches for food allergy. By bringing together leading scientists in and related to the field of food allergy, and
the promotion of young scientists and scientists from groups underrepresented in the field, our objective is to
spark collaborations and new paradigms that will accelerate the growth of the food allergy research field and to
nurture and develop the next generation of emerging clinical food allergy investigators. Further, we hope to
significantly increase participation of early and mid-career investigators over more established thought leaders
and take full advantage of the GRC format to encourage robust scientific interaction and discussion among
participants from a wide range of institutions. We propose to employ best practices in conference planning
including representation of across gender identities, underrepresented groups, diverse racial backgrounds and
geographic regions, and adhere to GRC Code of conduct which includes zero tolerance policy for discriminatory
behavior on the basis of identity, and zero tolerance for physical, verbal or sexual harassment. The 2024 Food
Allergy Gordon Conference & Seminar will focus on emerging science in food allergy obtained from human
immunology, mouse models, and clinical trials. This conference will highlight advances in our understanding of
basic immune mechanisms of allergy and tolerance to foods by focusing on emerging science obtained from
mouse models, human immunology, and clinical trials. Novel areas of concentration include key systems that
interact with and shape immunity, including microbiome, the nervous system, and the skin-gut axis. We will also
highlight science supporting emerging treatment approaches for food allergy. This conference and preceding
seminar aims to stimulate discussion among investigators from multiple disciplines and disease areas, with the
goal of developing a universal language for all stakeholders to improve clinical care practices, facilitate research
to better understand the disease processes, and improve current and novel therapeutics.

Public health relevance
Project Narrative Food allergy affects 8% of the US population and is a significant economic and quality of life burden; food allergy also disproportionately affects Black and Hispanic populations. To develop new prevention and treatment approaches, diverse groups of scientists with interest and innovate research in and around food allergy topics need to be gathered to spark collaboration and novel research ideas. This is the objective of the 2024 joint Food Allergy Gordon Research Conference and Gordon Research Seminar.